Administration Core

ADMINISTRATIVE CORE – SUMMARY
Men are more likely to develop cancer than women in nearly every non-reproductive tissue type. Bladder cancer
typifies this sex-bias phenomenon as the male-to-female risk ratio ranking 1st in mortality and 2nd in incidence.
This male-bias persists even after adjustment for other known risk factors, supporting the idea that a fundamental
biological process(es) underlies sexual dimorphism. The overall goal of this Program Project Grant (PPG) is to
elucidate the molecular and cellular mechanisms underlying sex-biased incidence and mortality seen in bladder
cancer. The Administrative Core (Admin Core) provides the leadership for overall scientific direction and program
oversight and administrative, fiscal, and organizational coordination of all research activities of Projects and
shared Resource Cores. The Specific Aims of the Admin Core are as follows. Aim 1: To provide leadership for
overall scientific direction and program oversight. This includes setting the research agenda focused on
advancing basic understanding of sex differences in bladder cancer. The Admin Core will oversee programmatic
activities including scientific integrity, data management and ensuring data integrity, and direct expenditures.
Aim 2: To facilitate communication and integration of the PPG investigators and Resource Core leaders. In
addition to regular monthly virtual and in-person progress updates and communications, the Admin Core will
facilitate constructive review and enhancement of research progress through frequent and deliberate interactions
with subject matter experts via Internal and External Scientific Advisory Committees. Aim 3: To provide overall
administrative and fiscal management support. This includes ensuring compliance with all terms and conditions
of the grant, and consulting and communicating with extramural NCI/NIH staff in submitting all necessary internal
and external research reports. The Admin Core will also establish and monitor policies for inclusion of women
and ethnic minorities in research related to sex differences in bladder cancer.

Public health relevance
ADMINISTRATIVE CORE – NARRATIVE The Administrative Core (Admin Core) will provide critical services to support the overall integration and management of this P01 Program Project Grant that is distributed among two academic research institutions. The Admin Core will oversee and manage the progression of research milestones across the three Projects and two shared resource Cores. The Admin Core will catalyze scientific collaborations among the research team members; facilitate the sharing, integration and dissemination of knowledge and data; and ensure accountability and regulatory compliance with all institutional, state, and federal requirements and laws.